Novel, Non-Toxic Ocular Antiseptic For Intravitreal Injection Therapy

PROJECT SUMMARY / ABSTRACT
The objective of this Phase 2 proposal is to further develop a novel, non-toxic ocular antiseptic. Intravitreal
injection therapy (IVT) is one of the most commonly performed procedures in all of medicine, with approximately
6 million injections in the USA in 2016. Ocular antisepsis is required for patient safety, and multiple studies have
shown dramatically higher rates of blinding eye infections in patients who did not receive ocular surface
sterilization prior to IVT. The only FDA-approved antiseptic for ocular use is Povidone-Iodine 5% (PI, brand
name: Betadine® 5%; Alcon, Fort Worth, TX). PI leads to marked corneal epithelial toxicity in humans, resulting
in debilitating side effects including decreased visual acuity and pain that can last more than 3 days post-IVT
To address the limitations of Betadine, IRX-101 has been developed as a novel, non-toxic antiseptic for use on
the eye. The proprietary mechanism of action avoids the use of iodine, the active agent in PI responsible for
ocular toxicity. Pre-clinical testing of IRX-101 has demonstrated near-complete bactericidal effect in 30 seconds
of exposure time compared to 2 minutes for Betadine. In addition, IRX-101 has been found to have superior kill
of methicillin resistant staphylococcus aureus and epidermidis, which is of particular importance given the
increasing rise of these resistant bacterial strains. Finally, in stark contrast to PI, IRX-101 has demonstrated a
remarkable lack of ocular toxicity in preclinical rabbit studies.
In this proposal, we aim to advance IRX-101 into human clinical trials. To accomplish this goal, we intend to
submit an Investigational New Drug application with FDA, followed by initiation of a Phase 1/2 clinical trial
investigating the safety of two formulations of IRX-101. The results of the Phase 1/2 trial will guide the selection
of the final IRX-101 formulation and allow us to launch our Phase 3 clinical trial program. If successful, this
project will lay the groundwork for FDA approval and commercialization of IRX-101, a drug with the potential to
transform the safety and tolerability of IVT for patients in the USA and around the world.
!

Public health relevance
PROJECT NARRATIVE Ocular antisepsis with Povidone-Iodine 5% (brand name: Betadine® 5%; Alcon, Fort Worth, TX) prior to intravitreal injection therapy results in significant corneal toxicity and patient discomfort for up to 3 days. This affects hundreds of thousands of patients, many of whom receive multiple intravitreal injections per year. We propose to initiate clinical testing of IRX-101, a novel antiseptic with shorter antimicrobial kill times and near complete absence of ocular toxicity, generating data to support the FDA approval of a medicine that improves vision outcomes by delivering a safer, more tolerable injection. !